Neuroimaging Reveals Treatment-Related Changes in DLD: A Randomized Controlled Trial

Project Summary/Abstract
Developmental language disorders (DLD), a prevalent preschool disorder, can result in life-long impacts on
academic and career achievement. Although the impact of DLD can be mitigated through evidence-based and
efficacious interventions, not all children with DLD respond to these treatments, creating a challenge in the
management of this developmental disorder. To date no studies have tested the hypothesis that grammar
learning is mediated by baseline neurobiological function (underactivation and reduced connectivity between
regions in the network supporting procedural learning including inferior frontal cortex, motor cortex, basal
ganglia, and cerebellum). However, identifying the neurobiological foundations of DLD could reveal the neural
basis of grammatical learning deficits; as well as of treatment-related change. Assessment tools based on
behavioral methods richly characterize behavioral phenotypes, but may not provide insights into the neural
mechanisms underlying treatment-related change and therefore are insufficient in the management of DLD.
This proposed research will examine the contributions of neuroimaging in describing the neural basis of
grammar learning in treatment response. A randomized controlled trial (RCT) comparing a PI-designed
efficacious treatment to no treatment is the essential next step needed to guide evidence-based decision
making for this prevalent population. We will gather critical information regarding grammar learning in
preschoolers with DLD before, after, and following a break in intervention (i.e., computer-assisted treatment for
the DLD treatment group, “business as usual” for DLD no treatment controls). We will also include a
comparison group – typically developing (TD) preschoolers – to inform development versus disorder.
The overall objective is to provide novel insights into the neurobiological basis of grammar deficits while
also describing response to treatment. Our central hypothesis is that treatment designed to improve procedural
learning will improve structural and functional connectivity in related networks (assessed using structural and
functional MRI) and that the underlying neurobiology of grammar deficits is related to response to treatment.
Building on a robust history of recruitment and treatment of preschoolers with DLD, we will enroll 184
preschoolers, 100 with DLD (n=50 treatment; n=50 no treatment controls) and 84 TD. Aim 1 will establish the
relationship between functional and structural connectivity for preschoolers with DLD and their TD peers
between regions in the procedural learning network. In Aim 2, we will evaluate the efficacy of treatment in
significantly changing functional and structural connectivity in the procedural learning network (DLD only) and
that treatment-related changes might occur into the typical range (DLD and TD). To meet our scientific goals,
we pair behavioral tools (traditional grammar tools) with neuroimaging to describe mechanisms underlying
grammar learning and treatment-change. This research will establish the first estimates of how baseline
neurobiological function impacts response to treatment, critically needed for the management of DLD.

Public health relevance
Project Narrative Children with developmental language disorders (DLD, aka specific language impairment), one of the most common disorders in young children, experience hallmark grammar deficits. While there are effective intervention programs for addressing these grammar deficits, not all children respond to these treatments. Our traditional behavioral approaches to measuring outcomes following intervention have been insufficient in explaining how response to treatment occurs in DLD and as such, this project uses neuroimaging with the goal of identifying the brain mechanisms that support grammatical learning and how they relate to response to treatment in preschoolers with DLD.